Vanderbilt-Nigeria Building Research Capacity in HIV and Non-communicable Diseases (NCDs) (V-BRCH) 2

ABSTRACT
The Vanderbilt-Nigeria Building Research Capacity in HIV/Non-communicable Diseases (NCDs) 2 (‘V-BRCH
2’) renewal application is a coordinated approach to continue to build the capacity of Nigerian investigators to
successfully initiate and implement high-quality clinical studies in HIV-associated NCDs. V-BRCH continues to
build on the long-standing and highly successful collaborations between leading research institutions in Nigeria
and the United States - Aminu Kano Teaching Hospital (AKTH)/Bayero University Kano (BUK) and Vanderbilt
University Medical Center. V-BRCH 2 will support the creation of the next generation of highly skilled physician
scientists at AKTH through long-term (PhD and master’s level) training to investigate complex scientific
questions related to HIV-associated NCDs (Aim 1). We will continue to solidify an atmosphere of continuous
mentoring and skills acquisition for Nigerian physician scientists in HIV-associated NCDs via short- and
medium-term learning opportunities, paired mentoring arrangements, and competitive seed grants to mentor-
mentee teams (Aim 2). V-BRCH 2 will also leverage training activities conducted by Fogarty International
Center (FIC)-funded training programs in Nigeria and other African countries (South-South collaborative
opportunities) taking advantage of complementary courses, peer-to-peer group learning, and networking
opportunities. We will support advanced grant writing instruction, mentorship, and leadership training to V-
BRCH 2 trainees to optimize their transition into independent investigators and mentors (Aim 3). To this end,
we will select 10 junior faculty (“fellows”) per year to attend the annual two-week Nigeria Institute for Research
Development and Ethics (“NIRDE”) research development program in Kano, Nigeria. A Mentorship and
Leadership Faculty Development Program targeted to AKTH/BUK faculty who mentor MScPH and PhD
students will be developed, in addition to the creation of a virtual “Community of Scholars” that will ensure that
V-BRCH 2 trainees gain knowledge and skills for successful careers in HIV-NCD research in a conducive peer-
led environment. V-BRCH 2 represents the continuation of years of collaboration in research and training
between Vanderbilt and AKTH and will solidify the foundation for sustainable development of clinical research
focused on HIV-associated NCDs in Nigeria.

Public health relevance
NARRATIVE As Africa’s most populous country, Nigeria is one of several nations facing the threats of high HIV burden, low combination antiretroviral treatment (ART) coverage, and slow decline in new HIV infections. While ART programs have turned HIV into a chronic condition, morbidity from HIV-associated NCDs is becoming more common as HIV-infected individuals live longer, encumbering an already undercapacitated health system and emphasizing the need to develop clinical research capacity to generate evidence to tackle the burden of HIV and NCDs in Nigeria. In response to this need, this renewal application Vanderbilt-Nigeria Building Research Capacity in HIV/Non-communicable Diseases (NCDs) (‘V-BRCH 2’) program continues to harness the longstanding and highly successful research partnership between Aminu Kano Teaching Hospital/Bayero University Kano in Nigeria and the Vanderbilt Institute for Global Health to sustain a research training platform that will create a cohort of highly-skilled Nigerian investigators with the capacity to lead independent clinical research focused on the intersection of HIV and NCDs.